Chronic graft-versus-host disease

This effort continues to be very productive as evidenced by the yearly publication output related to GVHD, including publication of the Branch initiated imatinib clinical trial. In addition, I have made several important contributions to the identification of novel skin manifestations of cGVHD, as well as identified the role of total body irradiation as a risk factor for cGVHD. Current projects including ssRNA analysis of cutaneous GVHD specimens to better understand the pathophysiology of skin disease. Clinical projects including the first topical study of ruxolitinib for skin GVHD and a case series on cutaneous calcinosis in skin GVHD.